In Vivo Testing and Instrumentation Module

SUMMARY – IN VIVO TESTING AND INSTRUMENTATION MODULE
The In Vivo Testing and Instrumentation (IVTI) module provides our participating faculty with a comprehensive suite of
resources to speed up the pace of discovery for their in vivo investigations. These resources span imaging, mechanical,
and optical equipment with accompanying usage expertise and design guidance. In vivo testing, both with commercial
and custom instrumentation, is essential for many of the lines of investigation pursued by our participating faculty. As
advances in optical imaging, microelectronics, and neuroengineering continue to accelerate, the lines between these
formerly distinct research silos begin to blur. The IVTI module provides both early-stage and more established
investigators with the equipment, training, and resources to evaluate visual system structure and function with both
conventional and customized instrumentation. The IVTI module gives access to equipment and training in the in vivo
measurement of retinal structure and function. When these existing tools are insufficient for the needs of our
investigators, the IVTI module directors will guide and train on the conception, development, and design of custom
research devices to meet the needs of our participating faculty. Once a design has been developed, the IVTI module will
also provide state-of-the-art resources to fabricate the new device, as well as expert advice along the way to maximize
the likelihood of success. Taken together, these resources will allow our participating faculty at the University of
Pittsburgh and Carnegie Mellon University to access a modern toolkit for in vivo testing, providing both established tools
and a rapid prototyping mechanism to develop the next generation of in vivo testing and instrumentation that will drive
future discoveries.